Equipment Supplement to 1R01GM141391-01A1 (Easily Used Kits to Evolve Reagents that Covalently Tag and Inactivate Proteins)

Equipment Supplement for 1R01GM141391-01A1
(Easily Used Kits to Evolve Reagents that Covalently Tag and Inactivate Proteins)
Foundation for Applied Molecular Evolution
Steven Benner
Abstract
The Foundation for Applied Molecular Evolution (FfAME) holds a current NIGMS R01 research
award (R01GM141391, Easily Used Kits to Evolve Reagents that Covalently Tag and Inactivate
Proteins). Under this award, FfAME is requesting supplemental equipment funds that will be
used to replace a 16-year-old BioRad PMI phosphorimager, an instrument that serves as the
workhorse for the R01 project.
The main goal of the funded R01 grant is to utilize FfAME’s artificially expanded genetic
alphabet (AEGIS) to develop a platform to create receptors, ligands, and catalysts on demand.
These molecules can be used to covalently modify, tag, and destroy proteins that are chosen by
researchers and clinicians to target and solve many scientific, diagnostics, and disease
management problems.
This administrative supplement, if granted, will facilitate the purchase of an Amersham
Typhoon Biomolecular Imager, which will replace the BioRad PMI and will serve a critical role
in the success of the funded R01 project.

Public health relevance
Equipment Supplement for 1R01GM141391-01A1 (Easily Used Kits to Evolve Reagents that Covalently Tag and Inactivate Proteins) Foundation for Applied Molecular Evolution Steven Benner Narrative The Foundation for Applied Molecular Evolution holds an active NIGMS R01 award, 1R01GM141391-01A1 (Easily Used Kits to Evolve Reagents that Covalently Tag and Inactivate Proteins). As a current NIGMS R01 awardee, this request for additional equipment supplement funding is being submitted in response to PA-20-272, Administrative Supplements to Existing NIH Grants and Cooperative Agreements and to NOT-GM-22-017, Notice of Special Interest (NOSI): Administrative Supplements for Equipment Purchases for Select NIGMS-Funded Awards. The supplemental equipment funds being requested will be used to replace an outdated, discontinued instrument, for which parts and repairs are scarce, and will serve a critical role in the success of the funded R01 project.